Mechanistic studies of E3 Ub ligase in peroxisomes and mitochondria

Summary
Given the central role of mitochondrial dysfunction in disease and accumulating data linking peroxisomal
dysfunction with disease development, understanding the mitochondrial arm of the UPS and its crosstalk with
other organelles, such as peroxisomes, is critical. With current trends toward the aging population, developing
therapies for these diseases is a critical need. Strategies primarily aimed at neutralizing toxic reactive oxygen
species (ROS) have only partially succeeded. Thus, new treatment options with independent modes of action
are needed to improve the success rate of current therapies. The proposed work directly responds to this need
and will provide critical insights into the regulation and function of mitochondrial and peroxisomal quality control
and biogenesis pathways. Extensive evidence supports the vital role of the ubiquitin (Ub) proteasome system
(UPS) in mitochondrial function. Mitochondrial ubiquitination requires factors, such as the prototypical outer
mitochondrial membrane (OMM) E3 Ub ligase MARCH5, that uniquely target many mitochondrial pathways. Our
new data indicate that MARCH5 activity is also vital for peroxisomes. These organelles host diverse oxidative
reactions and play an essential role in fatty acid β-oxidation to generate energy intermediates for ATP production
by oxidative phosphorylation (OXPHOS). The preliminary data also show that a subset of MARCH5 localizes to
the peroxisomes and controls the abundance of peroxisomal proteins, peroxisome size, and maturation. We will
investigate the role of MARCH5 in the biogenesis of mitochondria-derived pre-peroxisomes and in protecting
mitochondria against the toxic effects of abnormal accumulation of peroxisomal proteins in the mitochondria
when peroxisome biogenesis is defective. A model that we recently developed in which cells exclusively rely on
oxidative phosphorylation (OXPHOS) for ATP generation shows that bioenergetic shift from glycolysis to
OXPHOS induces (i) degradation of MARCH5 client proteins associated with (ii) increased expression of the
OXPHOS proteins, (iii) enhanced capacity of mitochondria to generate ATP, and (iv) proliferation of
peroxisomes. These changes were reduced in MARCH5-/- cells and differently affected by distinct MARCH5
mutants. We will test the central hypothesis that, through its mitochondrial and peroxisomal functions, MARCH5
controls the metabolic adaptation of the cell to varying energy substrates. We combine biochemical, state-of-
the-art imaging, and gene editing methods to address the following questions: (1) What is the role, cofactors,
and mechanism of MARCH5 in peroxisomal biogenesis? (2) What domains and cofactors control MARCH5
specificity toward distinct mitochondrial and peroxisomal proteins and modes of protein degradation? (3) How,
through MARCH5 activity, does the bioenergetic status of the mitochondria control cellular energy balance and
sensitivity to cell death in healthy cells and cells from "peroxisome-biogenesis" disease-affected patients?

Public health relevance
Project narrative: The goals are to determine the mechanism(s) that control the mitochondrial arm of the ubiquitin (Ub) proteasome (UPS) system and test the role of mitochondrial E3 Ub ligase in peroxisomes. Completing these studies will address several critical knowledge gaps, such as the role of mitochondria as a signaling platform in de novo peroxisome biogenesis and how cellular energy metabolism controls MARCH5 activities, including its role in peroxisomal biogenesis and cellular adaptation to varying energy substrate availability. Characterizing these processes in molecular detail should lead us to novel therapeutic targets for numerous mitochondria and peroxisome dysfunction-linked diseases.